PARENT-OFFSPRING ALCOHOL USE ACROSS SEVENTEEN YEARS

The aims of this Project are to investigate the relationships over time between parents' alcohol use (1960) and that of their adult offspring (1977) as conditioned by offspring's: (a) perception of parental drinking, (b) early family experiences, (c) adult life events, (d) drinking network, and (e) life phase. A profile will be developed for identifying both individual and combinations of factors related to healthy drinking practices. This Project is a secondary analysis of data from the Tecumseh Community Health Study and will use two samples drawn from this "normal" drinking population. Study #1 (Parent-Offspring) consists of alcohol usage from 452 sets of parents (1960) and their adult offspring in 1977 and allows tests of relationships over time including a control on similarities in life phase. Study #2 (Longitudinal, Offspring) will test for changes in adult offspring drinking levels as reported in 1960 and repeated in 1977 as a 17-year longitudinal follow-up and as compared to both reported and perceived parent drinking levels in 1960.